Career Enhancement Program (CEP)

CEP Project Summary
The investigators assembled in the DF/HCC Kidney Cancer SPORE have a substantial record in mentorship
and enhancement of junior faculty working in the kidney cancer field (detailed below). The goal of the Career
Enhancement Program (CEP) of our SPORE is to build upon this record and continue a formal process for
the identification, selection, funding, and mentoring of individuals pursuing careers in the study of the basic,
translational, and clinical aspects of kidney cancer. This Program will rely on the infrastructure created by the
Administrative, Evaluation, and Planning Core (Admin Core) to:
1. Solicit CEP Award Applications
2. Evaluate Applicants and Select Awardees
3. Conduct CEP Evaluation and Review
4. Mentor CEP Awardees and promote Career Progress

Public health relevance
CEP Narrative: The CEP aims to attract and develop the next generation of translational investigators in kidney cancer.